Dynamics of RNA regulation and noncanonical translation between cell states

Project Summary
The genetic landscape of patient samples has illustrated a vast array of potential diagnostic and clinical
biomarkers through profiling of chromosomal rearrangements and examining subsequent alterations in RNA
abundance. However, genome-wide analyses have also discovered that there are discrepancies between
transcript expression levels and corresponding protein abundance, highlighting the limited predictive power of
bulk RNA-based prognostic strategies to assist in therapy. Moreover, there are an increasing number of studies
depicting thousands of missed and unannotated peptides. These discoveries underscore the importance of
understanding RNA regulation in the context of disease to showcase the complete landscape of genetic
expression and target the phenotype of malignant cells. Our findings have noted that select mRNAs are
translationally increased, independent of their transcriptional regulation, in response to disease progression,
and can be studied to create novel therapeutic avenues unique per disease type. Mapping post-transcriptional
regulation and the un-annotated proteome, including RNA localization and modifications to assist in
translational regulation, however, remains poorly understood. As cells rely on the dynamic response of protein
synthesis to quickly respond to environmental cues, this leaves an unexplored area for discovery that is
required for cell survival and is promising for innovative therapies.
We have identified essential signaling advantages activated to rewire RNA translation during initiation
and for the maintenance of aggressive disease states. During these processes, ribosome initiation is altered
and increased at non-canonical start sites, which can alter protein variants and produce micropeptides. Our
research focuses on mechanistically determining how growth and adaptive signaling cascades interact by: 1)
mapping the post-transcriptional aspects of gene expression missing from our current annotated genomes,
focusing on alternative ribosome initiation, and 2) investigating the RNA-modification and binding proteins
influencing selection and spatial interactions of RNA. This regulatory control rapidly reprograms the cellular
phenotype at the level of RNA translation, increasing genetic diversity, and we will be able to characterize the
global utilization of nonconventional initiation to study cell state changes modeled during cancer progression.
Our multidisciplinary approach is designed to connect unbiased ribosome sequencing with proteomic profiles
to identify the complete oncogenic proteome and the features that impose RNA selection. We will identify the
trans- factors, cis- domains, and RNA modifications utilized by adaptive signaling to commandeer the
translational response between cell states. Our studies will provide unprecedented insight into RNA regulation
through focusing on localization and modifications alongside ribosome initiation, and how their interplay alters
gene expression. This will lay the foundation for mapping genetic diversity through noncanonical translation.

Public health relevance
Project Narrative Gene expression relies on RNA regulation to orchestrate where and when a distinct transcript is translated to alter cell fate. These processes allow for dynamic responses to internal and environmental cues that can depict even where along an RNA translation initiation begins during the final stage of gene expression, enhancing genetic diversity through non-conventional protein synthesis. This proposal seeks to map the complete proteome during cellular growth and adaptation, while uncovering the regulatory mechanisms of RNA epigenetics in these processes, with opportunity for improved diagnostics and innovative RNA therapeutics in disease states.